Probing the particle size-viability relationship in bioaerosols through size-controlled measurements

Abstract
Bioaerosols are small particles suspended in the air that contain living organisms such as bacteria, fungi, and
viruses, and have caused some of the most severe and costly diseases, including the SARS-CoV-2 pandemic.
Among the various factors, the bioaerosol particle size plays a crucial role in all stages of transmission, including
the generation locations and mechanisms in the host's respiratory system, the suspension time and the traveling
distance (short-range vs. long-range), and the final deposition efficiency and location into the recipient's
respiratory system. Despite significant interest in this area over the past few years, current methods to generate
bioaerosols cannot produce bioaerosols with uniform size and sufficient quantity to allow reliable measurement
of pathogens that remain infectious over a long time period. Furthermore, no single method can cover the
complete size range of bioaerosols from the human respiratory system. As a result, the field has suffered from
the lack of capability to study important and basic questions, including how size in the entire respirable bioaerosol
range and respiratory activities (coughing, speaking, sneezing, etc.) influences how infectious pathogens
transmit under different environmental conditions (such as relative humidity, UV lights, ventilation). This
proposed research aims to address these critical limitations. Our central hypothesis is that the bioaerosol size
and size distribution due to respiratory activities have a significant impact on how the airborne pathogens stay
infectious in the air as a function of environmental conditions, and a virtual impact design produces monodisperse
pathogen-laden bioaerosols and in sufficient quantities to detect live pathogens to study the size-viability decay
rate relationship. We will test respiratory syncytial virus (RSV), which disproportionally affects infants under 2
years old. It is critical to understand how RSV is transmitted while there is scarce data in the area of RSV
transmission studies. The overall objective of this project is to design and build an easy-to-manufacture and
easy-to-use bioaerosols generation system and investigate the crucial role of size in the bioaerosol viability
decay under various environmental conditions. Our specific aims are (1) to determine the size-viability decay
relationship for RSV with monodisperse bioaerosols and (2) to estimate the viability decay rate of different
respiratory activities with a few well-characterized log-normal distributions. The success of this proposed work
will provide a new scientific tool to generate monodispersed bioaerosols with sufficient quantity for viability
assays and elucidate the key contribution of bioaerosol size on pathogen viability in different environmental
conditions. Furthermore, our work will reveal how respiratory activities impact pathogen transmission. These
tools and insights can lead to future studies on bioaerosol deposition in rodent and non-human primate lung
models.

Public health relevance
Project narrative To gain a deeper understanding of long-range airborne pathogen transmission, it is essential to investigate how pathogens behave within different sizes of bioaerosols under various environmental conditions. To achieve this, we propose a novel and easily constructed bioaerosol generator, which can produce monodisperse bioaerosols, making it possible to study the size-dependence of viable pathogen transmission. We will design and build the bioaerosol generator, and investigate the size dependent viability decay for Respiratory Syncytial Virus (RSV) under various environmental conditions.